Assessing the effects of oral pre-exposure prophylaxis on pharmacokinetics of monoclonal and vaccine-induced antibodies among women vulnerable to HIV-1

Abstract
In this proposal, we will determine the influence of oral pre-exposure prophylaxis (PrEP)
on the pharmacokinetics (PK) of passively administered monoclonal antibodies (mAbs) and
vaccine-induced polyclonal antibodies (Abs) in females vulnerable to HIV-1, using data and
specimens from past HIV-1 prevention trials. This research will have a significant impact on global
health because oral PrEP is currently the most accessible pharmaceutical HIV-1 prevention option,
and Abs are critical for immune protection and therapeutic efficacy.
Aim 1 focuses on determining whether oral PrEP affects the PK of VRC01, a broadly
neutralizing HIV-1 mAb, in female participants from the recently completed Antibody Mediated
Prevention (AMP) study. We will identify biomarkers of PrEP use that correlate with increased
mAb clearance, with a specific emphasis on assessing PrEP’s effects on two intestinal Ab
clearance mechanisms: disruption of the epithelial barrier and increased Fc receptor (FcR)
mediated Ab degradation. Aim 2 extends this investigation by examining the impact of oral PrEP
on the magnitude and durability of HIV-1 vaccine-induced antibodies (Abs) in female participants
from two completed HIV-1 vaccine efficacy trials. To extend beyond HIV-1, we will also assess
durability of Hepatitis B (HB) vaccine-induced Abs in female and male participants from AMP and
the vaccine trials. Consistent with what was observed for VRC01 PK in males from the AMP trial,
our preliminary data in two pre-efficacy vaccine trials suggest an association between PrEP use
and faster decay of HIV-1 vaccine-induced Abs. We plan to identify PrEP biomarkers associated
with vaccine Ab kinetics. In biopsy donors, we will also determine the association between HB
vaccine Ab kinetics and identified biomarkers with the two potential intestinal mechanisms of Ab
clearance. Characterizing any PrEP effects on Abs is crucial for people who take oral PrEP and
rely on mAb immunotherapies and/or Ab-inducing vaccines for protection against pathogens.
Aim 3 focuses on developing a pharmacokinetic and statistical modeling framework to
rank and select mAb regimens for efficacy testing. This framework will account for PrEP use and
mAb PK biomarkers identified in Aim 1. It will also incorporate mAb levels in serum and rectal
tissue from both males and females, recognizing the importance of tissue levels in predicting
protection against HIV-1 and intestinal PrEP effects on mAb PK. By building and validating
advanced PK models and statistical methods for bridging differences in study populations, we
seek to enhance the accuracy of selecting the most promising mAb regimens for future clinical
trials, ultimately contributing to more effective HIV-1 prevention strategies.

Public health relevance
Project Narrative Antibodies play a key role in treating diseases and preventing infections. Our previous study in men showed that oral PrEP, an affordable option to prevent HIV-1, affects how antibody levels decay over time. In this project, we will study whether this effect also occurs in women vulnerable to HIV-1, and determine PrEP’s effects on intestinal antibody decay. We will develop a model to select the most effective antibodies for prevention, considering their presence in blood and the areas where HIV-1 exposure and expansion occurs.